ARTFL LEFFTDS Longitudinal Frontotemporal Lobar Degeneration (ALLFTD)

ABSTRACT – ARTFL LEFFTDS Longitudinal FTLD: OVERALL SECTION
Frontotemporal Lobar Degeneration (FTLD) is the overarching term for a group of neurodegenerative disorders
that are believed to be caused by the accumulation of toxic protein aggregates in the CNS, most commonly
comprised of one of two major proteins–microtubule associated protein tau and TAR DNA binding protein
molecular weight 43 kDa. FTLD is at least as common as Alzheimer's disease (AD) in those under the age of
65. Due to the earlier age of onset and the rapid rate of decline, FTLD is thought to have an even greater
impact on the lives of patients and families when compared to AD. At least 20% of all FTLD patients have a
dominantly inherited familial disorder (f-FTLD), whereas the remaining patients have a sporadic FTLD
syndrome (s-FTLD). The current Advancing Research and Treatment in Frontotemporal Degeneration (ARTFL;
U54 NS092089) study enrolls and follows these s-FTLD patients. Approximately 50% of f-FTLD is the result of
one of three common mutations: the microtubule associated protein tau (MAPT), progranulin (GRN), or
chromosome 9 open reading frame 72 (C9orf72) genes. The current Longitudinal Evaluation of Familial
Frontotemporal Dementia Subjects (LEFFTDS; U01 AG045390) study enrolls and follows participants with a
known family mutation, while ARTFL also enrolls those with strong family histories but no known mutation. The
ARTFL LEFFTDS Longitudinal Frontotemporal Lobar Degeneration (ALLFTD) protocol represents our
plan to formalize the merger of the ARTFL and LEFFTDS studies to create an integrated North American
research consortium to study FTLD. The ALLFTD program, as implemented through this U19 mechanism, will
improve our infrastructure for comprehensive collection and sharing of data through creation of seven cores.
We address the main goals recommended by the National Alzheimer's Project Act (NAPA) Steering Committee
on the Alzheimer's Disease-Related Dementias (ADRD) focused on FTLD through these cores and two
research projects. ALLFTD will support many additional projects that address both the clinical and
neuroscientific goals recommended by NAPA ADRD by providing clinical data, scans and biological samples to
the scientific community. While there are no effective treatments for any FTLD disorder, increasing numbers of
new potential therapies are entering clinical trials. The ALLFTD program's commitment to supporting data
collection and sharing with researchers worldwide will foster development of disease-modifying therapies for
FTLD.

Public health relevance
PROJECT NARRATIVE for ARTFL LEFFTDS Longitudinal FTLD PROGRAM The ARTFL LEFFTDS Longitudinal Frontotemporal Lobar Degeneration (ALLFTD) protocol represents an expanded and integrated program involving seven cores and two projects with the intent of increasing data/samples/scans for investigative research in familial and sporadic FTLD, and ultimately promoting the development of effective therapies. The proposed project will enroll 2100 participants across 19 sites in the US and Canada, and by using the infrastructure built during the Advancement of Research and Treatment in Frontotemporal Lobar Degeneration (ARTFL) and Longitudinal Evaluation of Familial Frontotemporal Dementia Subjects (LEFFTDS) protocols, the ALLFTD cores will generate data that will be uploaded to the National Alzheimer’s Coordinating Center (NACC), biofluid samples that will be transferred to and processed at National Centralized Repository for Alzheimer’s Disease and Related Dementias (NCRAD), and imaging data that will be transferred to the Laboratory of NeuroImaging (LONI) - thereby providing data to qualified researchers worldwide. The cores will also contribute data and expertise to the projects, which will focus on asymptomatic/minimally symptomatic familial FTLD (Project 1) and overtly symptomatic familial and sporadic FTLD (Project 2).